HPV DNA HYBRIDIZATION--EARLY DETECTION OF GENITAL CANCER

This Phase II Cancer Control project will evaluate the feasibility of using filter in situ hybridization (FISH) for early detection of human papilloma virus (HPV) as a mass screening technique for females at higher risk of cervical and vulvar carcinomas. We will corroborate the sensitivity of FISH with Pap smears, coloscopy and/or biopsy results which are used currently as the standards for clinical and pathological assessment of normal/disease categories in cervical and vulvar lesions. A normal group of women (N=100) will be compared to groups of Cervical Invasive Carcinoma (N=87), Cervical Intraepithelial Neoplasia (N=41) (CIN), Vulvar Carcinoma (N=16) and Vulvar Intraepithelial Neoplasia (N=4) (VIN) for frequency of HPV types 6,11,16,18. Other potential risk factors will be compared between case categories and statistically associated with HPV DNA hybridization findings by group, using a self-administered questionnaire. Participants are comprised of women in Iowa, ages 20-79, Caucasian, who are seen at the University of Iowa Ob/Gyn and Gyn Oncology Clinics. The study proposes to compare reported sensitivity and specificity to our findings and to determine the PV+ of FISH for use in mass screening; to evaluate the efficacy with which genital specimens (smears and scrapings) can be collected by trained personnel during routine gynecologic exams for FISH assessment; to determine the costs/case; and to determine the feasibility of the laboratory technical effort required for using FISH as a mass screening technique. After testing the methodology and feasibility, we would develop a proposal to test the procedure (FISH) in a mass screening demonstration project (Phase V Cancer Control) in early detection of asymptomatic women at potentially high risk to genital carcinomas so they may be treated at an earlier stage; or so HPV+ women may be treated for these viruses to prevent dysplastic or carcinoma development. The use of the NCI Iowa-SEER cancer registry would present an ideal location for follow-up of disease development, as would the extremely low population mobility of the state.